Nextgen AD Models, Endotypes, and Screening

PROJECT SUMMARY
Alzheimer's Disease (AD) is a complex, multifactorial, slowly progressive, neurodegenerative disorder that
causes dementia and cognitive decline. It is common to delineate AD into familial AD (FAD) and late-onset AD
(LOAD), with the former with an early age of onset, having defined genetic origins (mutations in PSEN1, PSEN2,
and APP genes), while the latter has no specific gene mutations and the genetic background determinants are
unknown. Both AD forms manifest similar phenotypes, including memory loss and cognitive decline, the
formation of plaques and tangles in the brain and death. There is no known effective cure for AD. The major
barriers to our inability to identify drugs that will address this neurodegenerative disorder include (a) the absence
of reliable and accurate AD models that can faithfully recapitulate human AD, (b) a lack of incisive and
comprehensive understanding of the mechanisms (endotypes) underlying the onset and progression of the
disease, and (c) absence of screening strategies in the model systems to assess the efficacy of drugs that will
address all aberrant endotypes. Solutions to these barriers form the leitmotif of our proposal. Our first objective
is the development of brain organoids which are realistic models of the human brain from human induced
pluripotent cells (hiPSC). In aim 1 of the proposal, we plan to derive six isogenic mutant hiPSC lines (4 PSEN1,
1 PSEN2 and 1 APP) from a young, healthy individual. Similarly, derive isogenic mutation-corrected control
hiPSC lines from three FAD patients (each PSEN1, PSEN2 and APP mutations). Develop brain organoids from
these hiPSC cell lines and characterize them using biophysical and omics methods. In addition, we plan to
develop brain organoids from two aged non-demented control subjects. These brain organoids will be developed
with and without microglia additions and characterized using a repertoire of biophysical and omics methods as
a function of their development. We plan to investigate them at 1, 3, 6, and 10 months of organoid development.
These models will help us understand the role of genetic background in the disease process apart from the
deterministic FAD mutations. They will also help us understand AD disease evolution mechanisms (Aim 2) and
be a better tool for validating therapeutics screening (Aim 3). In Aim 2, We will use the multiome sequencing
methods to profile these organoids' molecular and cellular functional states. The multiomics measurements will
be analyzed using extant and innovative systems biology methods to identify "endotypes" that are disease-
causing and those that are distinct across the mutations and across time. We will relate these endotypes to the
biophysical and phenotypical measurements to develop causal mechanistic models that can help identify
potential disease mechanisms to target therapeutically. In Aim 3, we plan to validate the endotypes that are
disease causing using genetic perturbation strategies. Furthermore, we will test these model systems' validity
for investigating therapeutic screening and development as a preliminary step toward drug discovery.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease (AD) is the leading cause of dementia and affects millions of Americans, but it has no cure. The failure to develop drugs stems from a) the absence of accurate model systems that faithfully reflect human AD disease and can be used for research, b) the lack of knowledge of mechanisms that cause AD disease and its progression and c) the absence of a strategy to assess drugs that will address the disease. In this proposal, we will develop human AD organoid models, characterize disease mechanisms, and use them as a testing ground for treatments.